A clinical trial for psoriasis with novel single-cell genomic techniques to understand regulatory immunity behind long-term disease remission off drug induced by short-term IL-23 inhibition

Although highly effective, biologics targeting IL-23/Th17 axis should be continuously injected to
suppress recurrence of psoriasis. My long-term goal is to cure psoriasis without recurrence guided by
personal immune tolerance. The overall objectives in this application are to (i) identify regulatory immune
cell interactions induced by anti-IL-23p19 antibody administration in the skin of patients whose psoriasis
is cleared without recurrence and (ii) develop pre-treatment predictive models for psoriasis patients that
anticipate disease recurrence after short-term anti-IL-23p19 antibody injection. The central hypothesis is
that IL-23p19 inhibition promotes regulatory immune cells in psoriasis patients whose disease is cleared
without recurrence, and their pre-treatment single-cell immune signatures are different from those of patients
whose disease recurs. The rationale for this project is that molecular evidence of immune tolerance
induction by IL-23p19 inhibition in human skin is likely to offer a strong clinical framework whereby new
strategies to prevent recurrence of chronic inflammatory diseases can be developed. The central hypothesis
will be tested by pursuing two specific aims: 1) Testing the hypothesis that regulatory immune cell
interactions are promoted by short-term anti-IL-23p19 antibody administration in the skin of psoriasis patients
whose disease becomes clear without recurrence; and 2) Developing predictive models with pretreatment
skin biopsy single-cell genomic data that anticipate long-term disease clearance off drug after
short-term anti-IL-23p19 antibody administration. To achieve the specific aims, we have recently developed
two innovative complementary single-cell approaches to obtain gene expression profiles of heterogeneous
immune cells from psoriasis and control skin without enzyme digestion. The first single-cell experimental
approach is microfluidic partitioning of emigrating cells from human skin after 48-hour incubation
in culture medium without enzyme digestion, which empowers single-cell transcriptomic profiling of
heterogeneous immune cells and keratinocytes in different layers of epidermis under ex vivo condition.
The second single-cell experimental approach is Combinatorial indexing RNA sequencing, developed by
the co-mentor of the proposal, which enables co-profiling transcriptome and single-cell chromatin accessibility.
At the completion of the proposed research, our expected outcomes are to have novel single-cell
genomic techniques to study immune cell interactions in human skin, defined single-cell gene signatures
of regulatory immune cells that are promoted by anti-IL-23p19 antibody administration in psoriasis skin,
and the ability to elucidate how pathologic immunity is suppressed at the single-cell level by highly effective
biologics. We also expect to have pre-treatment biomarkers that can predict long-term disease clearance
off drugs after short-term anti-IL-23p19 antibody administration.

Public health relevance
Project Narrative The proposed research is relevant to public health because it represents a new and alternative strategy to cure psoriasis without recurrence after stopping treatments. The proposed research is relevant to the part of the NIAMS Immunobiology and Immune Disease of Skin Program that pertains to studying the regulation of skin immune responses and immune tolerance induction with novel single-cell approaches.